HEALTH Center for Addictions Research and Cancer Prevention

ABSTRACT
The proposed RCMI HEALTH Center for Addictions Research and Cancer Prevention is designed to establish a
national exemplar for how community-engaged research can accelerate scientific breakthroughs that can be
rapidly disseminated and implemented directly into the targeted community by trained laypersons or
paraprofessionals. This will be achieved by the successful completion of five specific aims: Aim 1. Execute a
centralized Research Infrastructure Core that will enhance scientific rigor, productivity, and impact of
health-equity science through five primary services: (1) Research Methodology; (2) Laboratory Techniques and
Facilities; (3) Data Management and Biostatistics; (4) Health Informatics; and (5) Responsible Conduct of
Research, Ethics, and Compliance in health-disparities research; Aim 2. Execute a group mentoring program in
the Administrative Core that provides data-driven career enhancement activities for underrepresented
minority (URM) postdoctoral fellows and assistant professors pursuing careers in health-equity science; Aim 3.
Strategically increase the application and success of investigators – underrepresented in the health sciences
– securing competitive NIH research grants through the Pilot Grant Program and Innovation Research
Talks administered by the Investigator Development Core; Aim 4. Leverage the Community Engagement Core
to facilitate equitable, collaborative, and sustainable partnerships with community members,
organizations, and stakeholders to enable a bidirectional “exchange of information” that advances the potential
impact of research findings for achieving health equity; and Aim 5. Promote research on minority health and
health disparities by disseminating RCMI outcomes through publicly available peer-reviewed publications,
presentations, white papers, policy briefs, and other materials, activities, or services disseminated into the
community. This transformative infrastructure – in partnership with UH administrators, community
members, stakeholders, organizations, and elected officials – provides a sustainable data-driven approach for
saving lives and preventing addictions and cancer from disproportionally afflicting marginalized and
underserved communities in metropolitan Houston and beyond.

Public health relevance
PROJECT NARRATIVE The diversity, population size, and health challenges of metropolitan Houston provides an ideal setting for a NIMHD Research Centers in Minority Institutions (RCMI). The University of Houston (UH) proposes to establish the Helping Everyone Achieve a LifeTime of Health (HEALTH) Center for Addictions Research and Cancer Prevention to advance institutional infrastructure to pursue cutting-edge health-equity science. Investing in health-equity science has the potential to save lives and improve the overall quality and length of life for some of our most vulnerable populations.